Center for Advancing Precision Neural Circuit-Based Rehabilitation (Neuro-PRECISE)

COMMUNITY ENGAGEMENT & OUTREACH CORE – PROJECT SUMMARY / ABSTRACT The goal of the Community Engagement & Outreach (CEO) Core is to maximize stakeholder engagement for the Neuro-PRECISE Center, including researchers, clinicians, students, the public, and, importantly, consumers of rehabilitation services and their care partners and support organizations (people with lived experience, PWLE). To have a significant impact, the Neuro-PRECISE Center must substantially integrate the voice and expertise of PWLE across all levels of the center (i.e., leadership, advisory committees, administration, research and resource cores, etc.), as well as disseminate critical research findings across the domain of rehabilitation research and to a national audience. Similarly, the CEO Core will work diligently to communicate and collaborate with other funded Medical Rehabilitation Research Centers (MRRCs) and the NIH/NICHD National Center for Medical Rehabilitation Research (NCMRR) to materially contribute to a national network that is greater than the sum of any single P50 award. The CEO Core aims, goals, and approach will be guided by NIH and National Academy of Medicine reports. The Core’s specific aims are to: 1) Engage the wider stakeholder community, especially People with Lived Experience. Engaging community stakeholders to ensure their voices permeate all levels of Center programming and planning is fundamental to realizing the vision of precision neurorehabilitation in a way that is meaningful and impactful for those we serve and with whom we partner. 2) Engage the neurorehabilitation research scientific community. The CEO Core will develop, implement, and continually enhance a catalog of services and tools geared towards the wider neurorehabilitation research community that includes ongoing quarterly webinars, high-quality trainings focused on precision neurorehabilitation both locally and as satellite symposia at national conferences, and collaborative opportunities with other funded MRRCs. 3) Develop and continually enhance the Neuro-PRECISE Center outreach initiatives, communication platforms, and website. Bi-directional communication is critical to the success of an effective research center – both for sharing important research findings and building collaborative research partnerships across the field of neurorehabilitation, and for keeping abreast of the needs and desires of the Center’s multiple stakeholders to drive the science in a direction that benefits everyone. Partnerships developed through open, bidirectional communication across a cadre of vested individuals who appreciate, and value different perspectives, expertise, and experiences are needed to solve complex problems. Including PWLE throughout Center components will allow PN scientists to better understand the needs of those living with disabilities and for continual improvement of research efforts.

Public health relevance
OVERALL – PROJECT NARRATIVE The Center for Advancing Precision Neural Circuit-Based Rehabilitation (Neuro-PRECISE) at the Medical University of South Carolina (MUSC) addresses a critical need for research infrastructure focused on identifying dysfunctional neural circuits, precisely targeting and modulating those circuits, and verifying that the circuits have been engaged to restore function for individuals with physical, cognitive, and psychosocial disabilities. The Neuro-PRECISE Center will be both a local and national resource for researchers by catalyzing cutting-edge research in PN to develop the next generation of rehabilitation interventions and to study and understand neuroplastic nervous system changes enabled by precise therapeutic modulation. Importantly, our research and outreach programs will be informed by active participation by People with Lived Experience (PWLE) across all levels of our center leadership and activities.